Single molecule biomolecular condensate analysis in neurons

PROJECT SUMMARY/ABSTRACT
Biomolecular condensates (BMCs) define small membraneless cellular compartments that segregate specific
proteins and nucleic acids to generate cellular functions. Fluorescence recovery after photobleaching (FRAP) is
currently the method of choice to characterize BMCs in vitro and in vivo and derive the average diffusion and
trapping of molecules trapped in these condensates. Although FRAP is a good way to retrieve these important
metrics, it greatly limits our understanding of BMCs nanoscale organization and dynamics in live cells and
precludes the analysis of nanoscale BMCs (below the diffraction of light ~200 nm). Single-molecule imaging
super-resolution microscopy allows direct imaging of molecules trapped in BMCs with much greater
spatiotemporal resolution both in vitro and in live neurons, and has the potential to reveal nanoscale BMCs and
their evolution in the context of ageing and Alzheimer’s disease (AD). However, there are currently no
bioinformatic tools to specifically analyze BMCs at the single-molecule level. We have developed a novel tool,
named Nanoscale Spatiotemporal Indexing Clustering (NASTIC), (Wallis et al., bioRxiv, 2021, ref. 7),
which offers unprecedented insights into the dynamics of proteins undergoing liquid-liquid phase
separation/transition in large and nanoscale BMCs, in live neurons. We identified Tau and synuclein as
candidates for their ability to generate synaptic BMCs in hippocampal neurons. NASTIC analysis reveals that
Tau molecules can indeed form small nanoclusters in live hippocampal neurons in which they exhibit very low
mobility and sensitivity to 1,6-hexanediol, an aliphatic alcohol used to inhibit weak molecular interactions that
mediate BMCs. NASTIC will be at the core of our ability to make a significant contribution to the understanding
of BMCs in neurons because it offers unprecedented opportunities to examine the spatiotemporal behaviour of
molecules in these condensates. NASTIC will be developed further to encompass two-color single-molecule
analysis. This will be instrumental to assess the spatiotemporal relationship of these nanoscale BMCs with their
cellular environment in 2 and 3D. We will validate our two-color NASTIC implementation with the pairwise dual
imaging of Tau wildtype and AD mutant P301L, and a-synuclein. This will allow us to decipher the co-clustering
dynamics and examine potential hierarchical dependency of one nanoBMC upon the other allowing refined
understanding of the generation of nanoscale BMCs in synapses. We anticipate that the P301L mutation will
largely increase the size and lifetime of the Tau nanoBMCs and alter their relationship with other synaptic
molecules.
The outcome of this grant will be the development and validation of an analytical pipeline that will enable
exploration of the spatiotemporal relationship of Tau and a-synuclein nanoBMCs in live hippocampal neurons.
Our project will therefore generate data and a much-needed technology opening new avenues for our
understanding of BMCs in neuronal function and AD.

Public health relevance
PROJECT NARRATIVE This project will develop and apply analytical technology enabling nanoscale characterization of biomolecular condensates (nanoBMCs) in living neurons using data from super-resolution single particle tracking imaging. Current BMC analyses mostly rely on fluorescence recovery after photobleaching (FRAP) on large BMCs which overlooks potential nanoscale BMCs likely to act as “seeds” for the generation of larger BMCs and of irreversible amyloids associated with Alzheimer’s disease (AD). Based on spatiotemporal indexing, our proposed analytical pipeline will enable characterization of the dynamic spatiotemporal nanoscale organization of wildtype and AD- mutant Tau and a-synuclein trapped in these enigmatic membraneless nanoscale compartments.